HPMPC PERIPHERAL CMV RETINITIS TRIAL

The purpose of this trial is to asssess the short term safety and preliminary efficacy of intravenous HPMPC (Cidofovir) for treatment of small peripheral CMV retinitis leions in patients with AIDS via a comparative randomized trial of HPMPC vs. odservation (no treatment) in an initial study population of up to 30 patients across 13 clinical centers. The purpose is also to evaluate the longer term safety, tolerance and efficacy of two regimens of intravenous HPMPC for treatment of CMV retinitis in patients with AIDS.